Expanding Mentorship and Neuroimaging Expertise in Patient-Oriented Studies of Brain, Behavior, and Age-Related Dementias

ABSTRACT
This K24 Midcareer Investigator Award in Patient-Oriented Research is a revision. The objectives of this
proposal focus on developing mentees at Vanderbilt University Medical Center, and expanding the research
expertise of the candidate. Specifically, this award will ensure that the candidate protected time to commit to
ongoing and expanded mentoring efforts of mentees engaging in clinical research that focuses patient-oriented
research, and acquire new imaging expertise that applies quantitative magnetic resonance imaging (MRI)
methods to patients who suffer from age-related neurodegenerative dementing disorders. This proposal will
allow the investigator to expand his research efforts into a new patient population, develop experience with
working in a programmatic research consortium, and advance clinical research efforts to addressing
neuroimaging biomarkers. The Career Development Plan focuses on training in high-field and ultra-high-
field MRI methods, where hands on training with expert collaborators and consultants will be supplemented
with coursework pertinent to the research objectives. Development in 3 tesla and 7 tesla methods will be
applied to a rare disease patient population with pure autonomic failure, who may convert to dementia with
Lewy Bodies, an Alzheimer Disease-related dementia. The Mentoring Plan is designed to focus on helping
mentees succeed in developing their academic research career. Specifically, the mentoring plan will ensure
that early stage neurologists who are applying for K-awards (i.e. K23, K01, and K76) will have appropriate
mentorship as they develop research methodologies, and build research expertise. Additional support from
consultants will allow the applicant to develop of a mentoring approach that is tailored to the physician-
scientist. There are extensive institutional resources at VUMC which will ensure completion of this goal. Finally,
the career development focus which develops new imaging techniques will be facilitated by the Research
Plan. This project will assess neurodegenerative changes that occur in patient with alpha-synuclein disorders.
These include the prodromal state of pure autonomic failure, as well as Parkinson’s disease, and Dementia
with Lewy bodies. The aim is to understand how changes to iron, neuromelanin, and macromolecular content
can be used as objective imaging biomarkers of age-related neurodegenerative diseases, advancing imaging
candidates that can quantitate severity and extent of these biologic changes. By acquiring data on patients
who are part of the Autonomic Rare Disease Consortium, the candidate can test the hypothesis that early
reductions in brainstem neuromelanin, elevated iron deposition, and elevated macromolecular content will
identify patients likely to convert from prodromal to central alpha-synuclein disorders. Integrating MRI data with
clinical observations from the detailed clinical investigations will allow improvements to prediction models of
disease conversion. Overall, this award will provide crucial support for to expand the expertise and mentoring
program of the applicant.

Public health relevance
PUBLIC HEALTH STATEMENT This mid-career investigator award in patient-oriented research will help establish the candidate’s mentorship and career development, allowing the candidate to investigate prodromal markers of neurodegeneration in age-related dementing disorders characterized by alpha-synuclein pathology. There is a need to identify prodromal states before patients have clinical symptoms of dementia and parkinsonism, ensuring greater likelihood that clinical interventions will modify disease progression. This research will provide important information in developing new quantitative measurements of degeneration in patients with prodromal, and clinically manifest, Lewy Body disorders, while allowing the candidate time to foster the development of mentees pursuing patient-oriented research.